Career Training in Emerging Adult Treatment Research

DESCRIPTION (provided by applicant): Although emerging adults (EA, aged 18-25) account for approximately one-fifth of all publicly funded treatment episodes, we know very little about whether existing alcohol treatments are developmentally appropriate. Most of our knowledge about alcohol interventions for this age group is from studies in college settings, but according to the National Survey on Drug Use and Health, only 53% of emerging adults with Alcohol Use Disorders (AUD) are in college. Treatments that alter social networks may be especially promising for emerging adults, because alcohol and drug-free social opportunities may be particularly scarce during this developmental period. To address these problems, Dr. Smith will develop and pilot test a Peer-Enhanced Community Reinforcement Approach (PE-CRA) intervention, in which close friends of emerging adults receiving publicly funded AUD treatments will attend therapy sessions. This application requests funds to provide the mentoring needed for Dr. Smith, an experienced clinician, to develop and investigate the efficacy of the proposed PE-CRA intervention. Dr. Smith will receive mentoring from two senior health services researchers, Drs Michael Dennis (primary) and Mark Godley (co-mentor), that focuses on knowledge gains in advanced data analytic skills for health services research (i.e., propensity score matching, methods for dealing missing data, analysis of moderators and mediators), clinical research designs and study implementation, knowledge about the EA period of development. Support from the K23 mechanism will relieve Dr. Smith from teaching duties and allow him to dedicate 75% effort toward developing this line of research. His other 25% effort will be dedicated to teaching addictions coursework to social workers. It is anticipated that Dr. Smith will secure independent research funding for further studies that improve our understanding of what characteristics of EA mediate treatment effectiveness.

Public health relevance
PUBLIC HEALTH RELEVANCE: As the prevalence of alcohol use disorders (AUD) peaks in emerging adulthood, developmentally appropriate treatments tailored to the specific needs of this population could have high public health relevance. This proposal studies treatments for emerging adults presenting for treatment in publicly funded settings, which is a large and understudied population. Project Narrative As the prevalence of alcohol use disorders (AUD) peaks in emerging adulthood, developmentally appropriate treatments tailored to the specific needs of this population could have high public health relevance. This proposal studies treatments for emerging adults presenting for treatment in publicly funded settings, which is a large and understudied population. __SpecificAimsTextDelimiter__ A. Specific Aims The prevalence of alcohol use disorders (AUD) peaks during emerging adulthood (EA, ages 18-25) (Chan et al., 2008; Chen, Dufour, & Yi, 2005; Grant, Moore, Shepard, & Kaplan, 2003). One would imagine then that developmentally-appropriate alcohol treatments would be widely available for this population, but in fact most treatments used with young adults were developed and tested primarily on older adults (Mason & Luckey, 2003). Sadly, studies comparing EA alcohol treatment outcomes to younger adolescents or older adults receiving similar treatments show that EAs have worse outcomes. Although there has been some recent work in college settings, over 53% (n=3,064,365 / 5,770,193 population estimate) of the EAs with AUD are not in college or other school settings (on-line runs on 2006 NSDUH at https://www.icpsr.umich.edu/SAMHDA/using-data/sda.html). Developing age-appropriate alcohol treatments for non-student populations of emerging adults (EAs) aged 18-25 should be a high priority (Arnett, 2000; Mason & Luckey, 2003; White & Jackson, 2005). Therefore, the main purpose of this study is to adapt an efficacious treatment (Miller et al., 1995; Roozen et al., 2004), called the Community Reinforcement Approach (CRA), for use with emerging adults. Variability in age is a prerequisite for conducting sufficiently powerful tests of interactions between treatment conditions and developmental stages in predicting treatment outcomes (Miller, Villanueva, Tonigan, & Cuzmar, 2007). Also, few studies have specifically focused on comparing emerging adult treatment outcomes in designs where members of this age group received two different treatment conditions. Thus, it is inherently difficult (and expensive) to determine whether or not one treatment is comparatively superior to another for a special population like EA. I propose to address this in two ways. First, I focus on an intervention that has demonstrated efficacy with both adolescents and adults (making it promising for young adults). Second, I make innovative use of a cost effective quasi-experimental approach that uses propensity score matching to statistically create an equivalent comparison group (Guo, Barth, & Gibbons, 2006; Rosenbaum & Rubin, 1983) from a large database that used common measures. Clinical researchers rarely integrate friends in alcohol treatments (Tevyaw, Borsari, Colby, & Monti, 2007) despite evidence on the importance of social support in the maintenance of problematic drinking (McCrady, 2004). Existing CRA procedures integrate family members, who reinforce the non-drinking behaviors of the identified AUD client. I hypothesize that peers may fulfill this role in the treatment of young adults, and will measure these behaviors to formally test whether these processes account for changes in participants' drinking behaviors. Much is to be gained since research rarely makes connections between proposed mechanisms of change and clinical outcomes. To address these knowledge gaps, I propose to adapt the Community Reinforcement Approach for use with young adults by addressing the following specific aims: Aim 1. To analyze the outcomes of heavy drinking and alcohol-disordered young adults receiving an innovative Peer-Enhanced CRA treatment (PE-CRA). Aim 2. To conduct exploratory analyses to identify both the treatment processes (i.e., peer reinforcement) and other factors (i.e., treatment appeal, alcohol-free social opportunities) that may mediate the effects of peer-enhanced treatments for young adults.